Role of TRIM11 in regulating TDP-43 and FUS

PROJECT SUMMARY/ABSTRACT
The overall objective of this application is to determine the role of TRIM11 in regulating transactive response
DNA-binding protein 43 (TDP-43) and fused-in-sarcoma (FUS) and protecting against TDP-43/FUS-related
proteinopathies. TDP-43 and FUS are prion-like RNA binding proteins (RBPs) with multiple cellular functions. In
healthy cells, these proteins reside predominantly in the nucleus. In various progressive and fatal
neurodegenerative diseases including amyotrophic lateral sclerosis (ALS), frontotemporal dementia (FTD),
limbic predominant age-related TDP-43 encephalopathy (LATE), and other Alzheimer's disease-related
dementia (ADRD), TDP-43 or FUS mis-localizes to the cytoplasm and forms cytotoxic inclusions in affected
neurons and glia, which is accompanied by their depletion in the nucleus and loss of their normal functions. What
regulates the solubility and function of TDP-43 and FUS is not well understood. This conspicuous gap in our
knowledge impedes the development of effective therapies. To maintain proteins in their functional soluble form,
organisms in all kingdoms of life rely on protein quality control (PQC) systems. Over the past decade, research
in my lab has revealed the existence of a unique and potent PQC system in animal cells, which consists of
tripartite motif (TRIM) proteins. We showed that individual TRIM proteins possess multiple activities to enable
protein folding, and they operate via a mechanism distinct from canonical, ATP-dependent PQC systems. More
recently, we demonstrated that TRIM11 prevents aggregation of a-synuclein and tau. Our preliminary data
further suggest that TRIM11 may also suppress TDP-43 and FUS misfolding and aggregation, and its expression
may be reduced in TDP-43 proteinopathies. Here, we propose to test the central hypothesis that TRIM11 is
critical for keeping TDP-43 and FUS in their functional soluble state, and its downregulation contributes to the
pathogenesis of TDP-43/FUS-related proteinopathies. We will (1) determine the role of TRIM11 in regulating
solubility and liquid-liquid phase separation of TDP-43 and FUS, (2) elucidate the effect of TRIM11 on the
localization and function of TDP-43 and FUS, and (3) define the role of TRIM11 in TDP-43/FUS-related
proteinopathies and explore its utility in disease treatment. Collectively, these studies will enrich our
understanding of protein homeostasis in animal cells and the pathogenesis of various devastating
neurodegenerative diseases. They will also provide valuable information for the development of effective
therapies.

Public health relevance
NARRATIVE Aggregation of TDP-43 and FUS causes relentlessly progressive and fatal neurodegenerative disorders such as amyotrophic lateral sclerosis (ALS), frontotemporal dementia (FTD), and limbic predominant age-related TDP- 43 encephalopathy (LA TE). This proposal will investigate a previously unrecognized role of TRIM11 in regulating the solubility and function of TDP-43 and FUS and explore its utility as a therapeutic agent. The insights generated from this work will shed important light on fundamental issues pertaining to the protein quality control in metazoans and the pathogenesis of neurodegenerative diseases and will likely aid in the development of effective therapies.